Encoding properties of bilateral CA3 inputs and their contribution to the formation and dynamics of CA1 spatial representations in novel environments

Project Summary: Memory enables animals to acquire, store, and recall knowledge of the world through
experience and use this knowledge to maximize reward and avoid danger. Understanding the circuit
mechanisms within and between brain regions that underlie the formation and recall of memories is considered
one of the great scientific challenges of our time and has the potential to drastically influence the treatment of
memory disorders. The hippocampus is both necessary and sufficient for the formation and recall of episodic
memories—memories of experiences placed in time and space. These memories are encoded in the
hippocampus by the firing activity of populations of neurons called place cells, which fire at specific locations
as animals move around their environment, creating a cognitive map. Understanding how cognitive maps form,
evolve with experience, and are retrieved is therefore essential for understanding the neurobiology of memory
and the function of the hippocampus in this process. However, a major pathway that has been overwhelmingly
neglected in the study of memory and the hippocampus is the across hemispheres projection between the CA3
and CA1 region of the hippocampus. This projection provides major excitatory drive to the CA1 region, yet
the information these projections convey to CA1 is unknown, as is their impact on CA1 memory encoding.
Technical limitations have prevented direct recordings and comparisons of within-hemisphere versus across-
hemisphere CA3 inputs to CA1 during memory processing.
To solve this problem, we will implement an innovative approach to directly measure and manipulate the
spiking activity of within-hemisphere versus across-hemisphere CA3 axons in CA1. We will also simultaneously
record the spiking activity of large populations of CA1 place cells during spatial learning — novel environment
exposure. Functional imaging of activity plus optogenetic manipulation of CA3 axons in hippocampus will
reveal the contribution of within-hemisphere versus across-hemisphere CA3 inputs on cognitive map
formation, evolution and retrieval. This will provide the first insight into the information being carried by
within-hemisphere versus across-hemisphere CA3 axons directly in CA1 during spatial learning and will reveal
how these inputs contribute to memory representations in CA1. These insights could reveal novel targets or
processes for the treatment of memory disorders.

Public health relevance
Project Narrative: These experiments will provide the first insights into the information being carried by bilateral CA3 inputs to bilateral CA1 during spatial exploration in a novel environment. They will reveal how these ipsilateral versus contralateral CA3 inputs independently contribute to the formation, refinement, and retrieval of memory representations in CA1. These insights into the mechanisms of memory processing in the hippocampus are critical for the development of appropriate strategies to treat patients with memory disorders.